Sumiki’s Acid, a de novo Dietary Compound Generated from Food Processing, Reprograms NK Cells for Cancer Immunoprevention

PROJECT SUMMARY/ABSTRACT
Immunoprevention has emerged as a promising approach to reducing cancer risk, with most efforts in vaccines
development, or repurposing of immune checkpoint inhibitors (ICIs). However, whether dietary small molecule
substances as effective immunomodulators for cancer immunoprevention is largely unknown. Emerging
evidence suggests a link between the de novo substances generated from food processing and
immunomodulation and a reduced risk of certain cancers. Considering the vital immunosurveillance roles of NK
cell against tumorigenesis, we hypothesize that certain de novo substances generated from food processing
may act as bioactive compounds (named deFPBioC) with immunomodulatory functions, exerting a direct and
specific influence on NK cells and related immunity to inhibit tumorigenesis. we assembled a novel deFPBioC
library and systematically examined their direct effects on NK cell-dependent cytotoxicity against cancer cell.
Sumiki’s acid (SKA), generated from Millard Reaction during food processing by hearing, or microbiota
biosynthesis, was identified as top candidate, which can significantly enhance the activation and cytotoxic
functions of both primary human NK cells and mouse NK cells. The oral administration of SKA boosts NK-
mediated anti-tumor immunity in various therapeutic mouse models, which encourages me to further determine
its potential as a cancer-preventive agent in spontaneous GEMM and carcinogen-induced colon cancer models
(Aim 1), and elucidate the underlying molecular mechanism (Aim 2). In addition, I aim to perform medicinal
chemistry studies for newly designed molecules with improved potency, and bioengineering of gut-microbiota for
SKA in situ production for more effective and sustain cancer-preventive effects (Aim 3). The scientific knowledge
and technical skills gained from these studies as well as my research training plan will help me develop a unique
research direction and facilitate transition into independence. I will extend my independent research by focusing
on the gut-resident immunity, investigating how de novo metabolites generated from microbiota-mediated
nutrient processing (named MicroNutriMetabolites, MNMs) regulate diverse gut residential immune cells and
related immunity response for colon cancer immunoprevention.

Public health relevance
Project Narrative: A comprehensive understanding of how de novo small-molecule compounds generated from food processing directly regulate various immune cells and contribute to effective cancer immunoprevention remains undefined. Employing innovative screening methodologies, our study reveals the novel role of Sumiki’s acid (SKA) as potent immunomodulator, reprogramming of NK cell functionality and anti-tumor immunity. This K99/R00 initiative seeks to test whether SKA is sufficient for cancer immunoprevention, and elucidate the underlying mechanisms, and to provide novel insights into the development of immunomodulators for cancer immunoprevention.